Fast and Accurate Cardiovascular MRI with Hyper 4D-Flow

PROJECT SUMMARY
Congenital heart disease (CHD) affects about 40,000 births per year (1%) in the United States. Estimates
indicate that over 1 million children and 1.4 million adults with CHD are living in the United States. This project
speciﬁcally aims to develop and clinically evaluate a magnetic resonance imaging (MRI) method to assess car-
diovascular hemodynamics in pediatric CHD patients, when imaging is most needed.
Individuals born with CHD require a lifetime of clinical care, especially during surgical planning and repair.
This includes monitoring and/or serial interventions that mandate multiple echocardiography, CT, or MRI exams.
Under most circumstances, MRI is the clinically preferred imaging modality for these patients owing to soft tissue
contrast, clear depiction of complex anatomies, capability to quantify cardiac function, and the lack of ionizing
radiation. Moreover, the ability to acquire 3D+time ﬂow encoded (“4D-Flow”) MRI exams that depict and measure
blood ﬂow dynamics is an increasingly impactful clinical tool in adult patients, but several challenges persist in
pediatric patients.
Current pediatric cardiovascular 4D-Flow exams are slow to acquire (⇡20-min with moderate spatial and tem-
poral resolution), have unacceptable ﬂow measurement accuracy and precision (oftentimes >20%), can have
long reconstruction times (several hours), and have inadequate clinical robustness (>10% of exams with unac-
ceptable image quality). These are unacceptable clinical limitations that interfere with clinical care. To overcome
these limitations, we have planned three speciﬁc aims to develop our Hyper 4D-Flow MRI exam. [AIM-1] To
enable fast, accurate, and robust image acquisitions with Hyper 4D-Flow. [AIM-2] To enable fast and accurate
image reconstructions of Hyper 4D-Flow. [AIM-3] To demonstrate the diagnostic value of “push-button” Hyper
4D-Flow in pediatric patients with CHD.
Successful completion of the proposed speciﬁc aims will make available a validated, “push-button”, multi-
vendor deployable Hyper 4D-Flow MRI exam that enables fast (5-min scan time and 30-min reconstruction),
accurate (<5% bias), precise (95%-CIs<5%), and robust measurements (>95% of exams with diagnostic image
quality; no need for post-acquisition corrections of background phase-induced errors) of blood ﬂow. This compre-
hensive approach to the problem will improve diagnostic accuracy and clinical conﬁdence in decision making for
pediatric patients with CHD patients, by providing fast, accurate, and robust evaluation of hemodynamics.

Public health relevance
PROJECT NARRATIVE Congenital heart disease (CHD) affects about 40,000 births per year (1%) in the United States and these children require life-long monitoring of their heart health. This project aims to develop, validate, and clinically evaluate a magnetic resonance imaging (MRI) method to measure blood ﬂow in pediatric CHD patients. We will disseminate a “push-button” MRI package to increase diagnostic accuracy and improve clinical conﬁdence in decision making for pediatric CHD patients.